Administrative Core

Project abstract
The proposal brings together an interdisciplinary team of investigators from Harvard University, Harvard
Medical School, Columbia, and UC Berkeley to uncover the function of dopaminergic neurons in controlling
action timing, selection, and reinforcement. The Administrative Core will provide support for interactions
among the team members as well as between the team, NIH, and external advisory board. In conjunction with
the Team Leader and the Internal Advisory Committee, the Administrative Core will also set timelines and
milestones, organize real and virtual meetings of the team members, monitor progress, and generate
corresponding reports.